Body Iron and Mental Health-Related Outcomes in Adolescents: A NHANES Data Analysis

Project Summary
Many psychiatric disorders, ranging from major depressive disorder to substance use and delinquency, emerge
or worsen during adolescence. These disorders are quite prevalent and associated with substantial distress and
impairment. They jeopardize one's trajectory towards a productive adulthood, and increase suicide risk and
involvement in crime. Because adolescence is characterized by dramatic physical development and the onset
of menses in females, this critical developmental period is also associated with increased risk for iron deficiency
(ID). Iron deficiency has been associated with neuropsychiatric impairment, including depressive and attention
deficit hyperactivity symptoms. This is not surprising, given iron's role in dendritic mitochondrial motility during
hippocampal neuron development, monoaminergic signaling, and myelination. In fact, across independent
samples of otherwise medically-healthy adolescents, we have found prevalent ID and an inverse association
between iron stores and the severity of psychiatric symptoms. Moreover, our preliminary evidence suggests that
body iron stores are associated with brain morphometry and connectivity, as captured by magnetic resonance
imaging. This work has resulted in a R01 award (1 R01 MH124848) to further examine how body iron stores
relate to brain iron stores, brain function, and psychopathology.
Only a few studies have examined the association between body iron stores and psychopathology in
adolescents and those that have suffer from substantial limitations. As such, this Small Grant (R03) application
seeks funding to use several waves of data from the National Health and Nutrition Examination Survey
(NHANES). This data set offers a unique opportunity given the availability of information on a large number of
adolescents (~900/wave) for several markers of body iron stores, depressive symptoms, inattention, substance
use, sexual activity, and sexually transmitted infections. As such, we will be examine the association of body iron
stores with depressive symptoms (Aim 1a) and with a composite score of externalizing behavior (Aim 1b). More
importantly, we also seek to determine the level of body iron stores at which problematic mental health-related
behaviors emerge (Aim 2). This is critical given that the ID has been defined by the medical field based on
anemia-related outcomes; however, preclinical and clinical data suggest that brain iron is depleted before anemia
emerges.
In sum, taking advantage of several NHANES data waves, this proposal will be the first to examine the clinical
correlates of body iron stores in a large group of adolescents, accounting for various confounders. Moreover, it
has the potential to make a substantial impact on the field by highlighting ID's neuropsychiatric effects at levels
of body iron stores higher than what has so far been considered medically problematic, requiring repletion.

Public health relevance
Project Narrative: Taking advantage of several waves of data from the National Health and Nutrition Surveys, this proposal will be the first to examine the clinical correlates of body iron stores in a large group of adolescents, accounting for relevant confounders. More importantly, it has the potential to make a substantial impact on the field by highlighting the neuropsychiatric effects of iron deficiency at levels of body iron stores higher than what has so far been considered problematic, requiring medical intervention.